Fibrin-neutrophil interaction in periodontitis immunopathology

Mucosal immune responses are key for the regulation of oral tissue homeostasis, but when disrupted will lead
to disease. Despite well-established appreciation of this general concept, specific mechanisms of oral mucosal
immunity are not yet completely understood. Mendelian diseases have been instrumental in understanding oral
health and disease by uncovering genes and pathways implicated in human immunity and mucosal homeostasis.
One Mendelian disease clearly linked to oral mucosal disease is Plasminogen (Plg) deficiency. Plg, is the
precursor of the active protease plasmin, which is the primary fibrinolytic enzyme in both intravascular and
extravascular space. Homozygous or compound heterozygous mutations in the human Plg gene (PLG) typically
lead to severe oral mucosal disease, suggesting a critical role for this protease in mucosal immunity. Indeed,
these patients present with fibrin deposition at mucosal sites and oral mucosal disease (ligneous periodontitis).
In ligneous periodontitis, excessive deposition of fibrin is hypothesized to lead to severe soft tissue and alveolar
bone destruction, and often results in the loss of the entire dentition in adolescence. However, the mechanistic
link between mucosal fibrin deposition and immunopathology is not yet understood. Mucosal inflammation and
fibrin deposition in areas surrounding the dentition and destruction of underlying bone are also the hallmarks of
the common form of periodontitis. Based on extensive preliminary data, Dr. Silva has formulated a central
hypothesis that mucosal fibrin deposition promotes periodontitis progression through the local engagement and
activation of infiltrating neutrophils. To test this hypothesis, Dr. Silva will pursue three specific aims: (1) Determine
the role of neutrophil-fibrin engagement in periodontal bone loss under compromised and normal fibrinolytic
conditions; (2) Determine the contribution of fibrin-neutrophil engagement for the induction of neutrophil effector
functions in vitro; and (3) Pharmacologically target fibrin-neutrophil effector functions to prevent periodontitis
bone loss. The mentored phase of this research will be conducted in the laboratories of Dr. Silva’s primary
mentors, Drs. Moutsopoulos and Bugge at NIDCR, which have all required equipment and facilities in addition
to an excellent intellectual environment for periodontal and fibrinolysis research. For scientific research training
and to help with her career growth, Dr. Silva has assembled a strong advisory committee to enhance her
knowledge in fibrin biology, immunology and neutrophil biology. She has also assembled an expert consultant
team to help her develop new research skills including live cell imaging and computer-based image analysis. In
addition, Dr. Silva will attend seminars, workshops and courses provided at NIH to improve her scientific
communication, grant writing, mentoring and leadership skills. This research, along with specific training
activities, will generate publications and preliminary data to help Dr. Silva to achieve her career goal of becoming
an independent researcher in the field of oral health and disease.

Public health relevance
Periodontitis is a common human mucosal chronic inflammatory disease characterized by destruction of tooth supporting structures, where severe and debilitating periodontitis affects 8-10% of the U.S. population. While it is well appreciated that host-susceptibility is a controlling factor of periodontitis development, a key knowledge gap is the identification of molecular determinants of host susceptibility that mediate severe periodontal disease. The goal of this research proposal is to understand how local fibrin-neutrophil engagement, a novel molecular determinant of periodontitis, mediates periodontitis pathogenesis in the context of both normal and compromised fibrinolysis.